The contribution of perivascular adipose tissue macrophages to microvascular dysfunction in obesity

PROJECT SUMMARY
Obesity causes microvascular dysfunction. The mechanisms that underpin the initiation and progression of
microvascular dysfunction are not known. This fundamental gap is a problem because microvascular
dysfunction precedes, and likely contributes to, the development of insulin resistance, hypertension, and type-2
diabetes. The perivascular adipose tissue (PVAT) that surrounds vessels plays a physiological role in
regulating vascular function. Preliminary data from the applicant’s lab show that proinflammatory macrophages
within the PVAT mediate microvascular dysfunction in obesity, and that macrophages release redox species
that impinge on microvascular function by modulating crosstalk between vessel nitric oxide and the gaseous
signaling molecule hydrogen sulfide. The objective of the current proposal is to define the role of PVAT
macrophages in the initiation and progression of microvascular dysfunction during obesity. The objective will
be accomplished by testing the central hypothesis that proinflammatory macrophages drive microvascular
disease during obesity by infiltrating the PVAT and releasing reactive nitrogen species, which limits nitric oxide
bioavailability and increase contractility by depleting vessel hydrogen sulfide. Three specific aims are
proposed: aim 1 will define the contribution of PVAT inflammation to the initiation and progression of
microvascular disease; aim 2 identify the paracrine signal that mediates communication between PVAT-
macrophages and the microvasculature, and aim 3 will define mechanisms by which PVAT-macrophages
affect microvascular signal transduction. A diet-induced mouse model of obesity will be used in combination
with macrophage depletion and tissue-specific knockouts. A comprehensive in vivo and in vitro analysis of the
interaction between PVAT, macrophages, and microvasculature will be performed in both male and female
animals by integrating data from intravital microscopy, pressure myography, confocal imaging of live
mesenteric arteriolar segments, and metabolic analyses. Completion of these aims will establish a new
paradigm in which recruitment of proinflammatory macrophages to the PVAT is a major catalyzing event in the
development and progression of microvascular dysfunction.

Public health relevance
PROJECT NARRATIVE This project seeks to define the mechanisms by which macrophages, cells of the immune system, cause microvascular dysfunction in obesity. Microvascular dysfunction is a serious health issue because it directly con-tributes to the development of hypertension, insulin resistance, and type-2 diabetes. Thus, the research is relevant to the NIH’s mission pertaining to the pursuit of fundamental knowledge about the nature of living systems that will lead to the prevention and cure of human diseases.